Mitochondrial bioenergetics and colorectal cancer

ABSTRACT
Relative to matched normal tissue, recent large scale sequencing efforts indicate that colorectal cancer (CRC)
tumors are specifically enriched in loss of function mutations in mitochondrial DNA (mtDNA); however, the
significance and functional consequences of high mtDNA mutational burden in CRC remains unknown. Given
that mtDNA encodes critical subunits in 4 out of the 5 complexes of the electron transport chain (ETC), high
mtDNA mutational burden suggests that CRC incidence and/or pathogenesis is dependent on disruptions in
mitochondrial respiration. On the contrary, impairing tumor mitochondrial respiration, via pharmacological ETC
inhibitors or deletion of genes required for the function of the respiratory complexes, blunts tumor growth across
many tumor types, including CRC. Together, these seemingly contradictory data sets highlight an intriguing
paradox: how do accumulated mtDNA mutations support CRC tumorigenesis, if mitochondrial oxidative
metabolism is inherently required for tumors to grow? Generating targeted and efficient CRC therapeutics is
dependent on answering this question. In preliminary studies using purified human CRC mitochondria we
confirmed that, relative to matched normal, CRC tumors have more mtDNA mutations and discovered that
functional bioenergetic deficiencies exclusively localize to mitochondrial complex I, with 100% (12/12) of clinical
CRC tumors displaying partial loss-of-function in complex I activity. To model human CRC bioenergetic
deficiencies in the mouse, we reduced complex I activity by 50% in the colon using tissue-specific deletion of the
complex I accessory subunit NDUFS4. Partial complex I inhibition increased both tumor number and size
following CRC initiation with AOM/DSS and induced a pronounced growth advantage in tumor-derived
organoids. These results demonstrate that partial complex I loss of function provides a growth advantage
sufficient to accelerate CRC outgrowth. Surprisingly, despite it's role as the initiating complex of the ETC,
complex I deficient CRC tumors respired normally; although at the expense of increased matrix NADH/NAD+.
Additional bioenergetic analysis revealed that CRC tumors circumvent NADH/NAD+ hyper-reduction to sustain
mitochondrial oxidative metabolism by uncoupling respiration from ATP synthesis. Thus, our preliminary data
indicate that CRC mitochondria exhibit unique metabolic rewiring that allows respiration to proceed despite
partial complex I inhibition. The goal of this project is to test the hypothesis that partial complex I deficiency
induces increased NADH/NAD+ and/or respiratory uncoupling that accelerates CRC growth. Successful
completion of this project will establish the mechanisms by which complex I deficiency accelerates CRC. Given
that complex I genes are the most frequently mutated mtDNA genes across tumor types, these findings will
provide broader insight on the interplay between mitochondrial function and cancer.

Public health relevance
PROJECT NARRATIVE Although colorectal cancer (CRC) is enriched with pathogenic mtDNA mutations, the role of the mitochondrion in CRC remains unknown. In this proposal, we will leverage our expertise in mitochondrial biochemistry, state- of-the art in vivo, in vitro, and ex vivo CRC models, and viral genetic manipulation to define the molecular pathways linking mitochondrial metabolism to CRC growth. By providing a mechanistic link between mitochondrial bioenergetics and CRC, this work will move the field forward in our understanding of the role of mitochondria in CRC, ultimately paving the way for CRC-specific mitochondrial interventions.